Advancing Non-Medical Risk Factor Research through a CBPR Lens: A Short Course

It is increasingly recognized that the future of nursing and healthcare research
must incorporate a clear understanding of non-medical risk factors—such as
economic conditions, environmental exposures, housing, education, and other
structural conditions—that significantly influence health outcomes. To address
persistent health differences and improve population health, there is a critical
need to develop educational and research strategies that extend beyond clinical
care to encompass these broader influences. Although frameworks and best
practices exist for training clinicians, there remains a substantial gap in preparing
researchers—particularly nurse scientists—to study and intervene on nonmedical
risk factors. Current curricula have largely focused on clinical practice,
leaving the research domain underdeveloped. Actionable research is urgently
needed to address upstream and downstream influences, life course processes,
biological mechanisms, and global data limitations. The nursing profession is
well-positioned to lead this work, given its longstanding focus on population
health and its deep engagement in care delivery and communities. To build
research capacity in this area, we propose a short course to prepare nurse
scientists and other health professional researchers to plan and conduct
community-based participatory research (CBPR) studies focused on non-medical
risk factors. The course will equip participants to identify, measure, and address
these factors across all populations. This evidence-based, scalable training
model supports rapid capacity-building and knowledge translation—key priorities
for NIH and NINR. The initiative addresses workforce development needs in
implementation science and advances research that informs policy, strengthens
interventions, and accelerates real-world impact.

Public health relevance
Project Narrative To tackle the increasing health-related challenges associated with SDOH, health The ideal way to prepare nursing and other professional health researchers with SDOH-related skills to generate critical change is to offer continuous training opportunities by way of short courses that include CBPR and intersectoral considerations.